Johns Hopkins Institute for Clinical and Translational Research

The Johns Hopkins Institute for Clinical and Translational Research (ICTR) has been a
productive, innovative and impactful organization in transforming how clinical and translational
research is conducted. Enhancing collaborative research teams, advancing informatics,
promoting new methodologies, providing access to regulatory support, and bringing researchers
and the community closer together as true partners in discovery have all made translational
research more successful. Over the next seven years, the Johns Hopkins ICTR will continue its
current research community as a comprehensive regional hub that includes partners – the
University of Maryland Baltimore (UMB), Hugo W. Moser Research Institute at Kennedy Krieger
Inc. (KKI) and Morgan State University (MSU). We will continue to work with collaborator Kaiser
Permanente Mid-Atlantic States (KPMAS), and add the University of Maryland Baltimore County
(UMBC) and the University of Maryland College Park (UMCP) as new collaborators. These
entities bring complementary expertise and connections to distinct populations in the State of
Maryland, with emphasis on underserved rural and urban areas. Together, we have an
opportunity to conduct high quality innovative research, and rapidly implement and integrate and
disseminate findings that impact the health of our state and region. Building on our extensive
connections with community groups, we will continue joint governance with bidirectional
communication and participation on key ICTR committees. We will focus on improving
methodologic and operational support for research teams conducting randomized clinical trials so
that the impact of these trials is enhanced. The ICTR provides a model for training investigators
to work in multidisciplinary teams with experienced mentors using the most rigorous
methodologies. Based on recent events we have added new programs on Research in Response
to National Emergencies and Dissemination and Implementation Core. Trust in research
organizations has been decreasing. Our research project is to evaluate whether return of
aggregate study results can increase satisfaction with research and trust in research. The ICTR
is poised to leverage our current services to benefit new partners who have extensive
responsibility for the conduct of research and health care delivery in Maryland. Working together,
we expect to have a measurable impact on translational research in Maryland.

Public health relevance
By identifying and overcoming barriers in the translational pathway, increasing scientific collaboration, providing consultative services, clinical research infrastructure, and technology cores that bridge the gap between the laboratory and the clinic, the ICTR helps to speed the pace of scientific discovery, bringing effective therapies to the public, and ultimately improving the health of Americans. Our large ICTR includes the universities and health system in Maryland that have the most research activity. We expect to leverage these organizations to create high impact research that can move Maryland to better health outcomes and health equity.